Core B - Molecular Pathology and Imaging Core (MPIC)

PROJECT SUMMARY – CORE B
The Molecular Pathology and Imaging Core (MPIC), Core B, is strategically designed to address the shared
needs for tissue processing, histopathology, imaging, and expert analyses and is integral to all three projects of
this P01. Established in 1995, the MPIC has been a critical part of this P01 since its inception in 2003 and has
served as a model core facility for numerous other program projects and centers at the University of
Pennsylvania and throughout the country. The overarching goal of the MPIC is to provide exceptional service
and support to the esophageal cancer P01 investigators and their laboratories and is accomplished through
two interrelated Specific Aims: (1) To provide essential, cost-effective, and high-quality services and support
to the P01 investigators and their laboratories for the preparation, sectioning, staining, and interpretation of
tissue sections, both animal and human, as well as cultured cells (interacting with CCiC), with particular
expertise and focus on 3D organotypic/organoid cultures; and (2) To assist in planning and optimizing (a) in
situ hybridization (ISH), immunohistochemistry (IHC), and immunofluorescence (IF) experiments, including for
immuno-oncology, and (b) microscopy and image analyses for the P01 members and their laboratories and to
provide training in these techniques, as well as perform these services as requested. The MPIC is led by an
experienced Director (Dr. Jonathan Katz), Technical Director (Mr. Adam Bedenbaugh), and expert Consultant
in esophageal and squamous cell pathology (mouse and human) (Dr. Andres Klein-Szanto). Integrating
resources and services across all project sites, the MPIC is a unique entity at the University of Pennsylvania,
the Medical University of South Carolina, the Dana Farber Cancer Institute and New York Institute with specific
expertise in processing and analyses of all 3D organotypic cultures/organoid cultures and tissues (mouse,
human) relevant to this P01. For P01 investigators and their laboratory personnel, the MPIC provides both
essential, routine services and advanced technologies and approaches. The MPIC also fosters cost-effective
approaches and promotes new and exciting directions for research. In addition, the MPIC offers special
benefits to members of this P01 that are not available to other users, including esophageal cancer specific
TMAs, significant subsidies for services, priority services, and access to Dr. Klein-Szanto, an expert clinical
pathologist. Moreover, through consistent and validated approaches and standard protocols, the MPIC helps
ensure rigor and reproducibility of experiments for P01 investigators and their laboratory members. Thus, the
MPIC provides exceptional utility, quality, value, experience, service, and commitment to this P01's projects,
cohesive coordination with other cores, and this P01 receives top priority.

Public health relevance
PROJECT NARRATIVE – CORE B The Molecular Pathology and Imaging Core (MPIC), Core B, provides essential, cost-effective, and high- quality services to all three projects of this P01 including for processing and analyses of relevant 3D organotypic/3D organoid cultures and tissues. To this end, the MPIC also houses instruments for immunohistochemistry, microscopy, and image analyses. Ultimately, the goal of the MPIC is to advance research for all of the P01 investigators.